Tissue Engineering of New Hair Formation

DESCRIPTION (provided by applicant): The objective of this proposal is to develop reconstituted skin that can form new hairs from dissociated stem cells. Progress has been made in producing hair follicles using dissociated multi-potential dermal and epidermal stem cells. However, couple gaps need to be filled before significant progress in clinical applications can be made. Recently, we have improved significantly the previous assays by Lichti and Stenn into a simpler hair forming assay with clinically proper appearance and potential for a high throughput assay. Our general hypothesis is that multi-potent skin stem cells can be generated by molecular reprogramming, and that arrangement and patterning of hair primordia can be regulated by environmental conditions. With the newly developed planar hair forming procedure, we are able to apply our expertise in feather pattern formation to regulate the number and size of hair primordia. We will also apply our recent experience on macro-environment regulation of hair stem cells to improve the efficiency of hair formation. Recent success of molecular re-programmig in other organs has inspired excitement. This simple assay will allow us to do high throughput analyses to identify molecules or combinations of molecules important to reprogram adult skin cells into hair forming dermal and epidermal cells. The development of this technology will bring new hope to those who suffer from severe wounds and alopecia.

Public health relevance
PUBLIC HEALTH RELEVANCE: Currently, over 100,000 patients are treated for burn injury in the United States per year, and burns can cause lasting cosmetic and functional defects to visible areas on the skin. Here we propose to develop a novel planar hair forming protocol which integrates progress from our parent grant and others hair research and may bring new hope to those who suffer from severe wounds, and alopecia. Narrative Currently, over 100,000 patients are treated for burn injury in the United States per year, and burns can cause lasting cosmetic and functional defects to visible areas on the skin. Here we propose to develop a novel planar hair forming protocol which integrates progress from our parent grant and others hair research and may bring new hope to those who suffer from severe wounds, and alopecia. __SpecificAimsTextDelimiter__ Specific Aims The current treatment of wounds can produce scar tissue which provides an adequate barrier to infection and water loss but does not contain sebaceous glands, sweat glands, hairs, etc. As increasing numbers of patients now survive severe burns and trauma there is a greater need to grow functional skin containing these skin appendages. Our overall goal is to apply stem cell engineering technology to form a reconstituted skin replacement that functions close to normal for these patients. This reconstituted skin must contain the appropriate components in the right ratio with the correct architecture. While this is our ultimate goal it is beyond the focus of the current proposal. Here we focus on using tissue engineering to produce reconstituted skin which can grow hair. Hair grows on the surface of the skin making it easy to measure hair follicle density, as well as the thickness and length of the hair shaft. So far progress has been made in the production of hair follicles as a model for organizing complex tissues using dissociated multi-potential dermal and epidermal stem cells from newborn mouse skin (Lichti et al., 1995; Lichti et al., 2008; Zheng et al., 2005). However several bottlenecks must be overcome before this line of research can be translated into useful clinical applications. (1) The procedure has to be simplified and standardized for realistic future clinical use. Lichti's procedure involving the insertion of a grafting chamber onto the wound bed is cumbersome and does not allow for a larger scale screening or future human application. Stenn's patch assay procedure allows large scale screening but leads to the formation of a hair cyst. (2) The reconstituted skin should produce hair follicles with proper topological arrangements. We want to modulate the number and size of hair follicles for different circumstances. (3) We want to identify factors that can help hair formation. A simple assay that allows high throughput screening will be very useful for future applications to human skin (Lee and Chuong, 2008). Here we hypothesize that skin progenitor cells can be activated and reprogrammed to form functional skin containing the appropriate number, size and alignments of skin appendages if they are first prearranged in a matrix dressing. We propose to further develop this technology to diminish the above roadblocks and accelerate progress in the field of hair reconstitution. We developed a simplified strategy to form hair follicles with a proper topological arrangement. The procedure has the potential to allow the modulation of the number and size of hair follicles. The size and shape of the field containing reconstituted hair follicles can be designed as desired. It also has the possibility to become a simple and widely used procedure for the high throughput screening of factors involved in skin stem cell reprogramming. This will be achieved by the following specific aims. A diagrammatic flow chart of activities involved in this proposal is presented in Fig. 1. Aim 1. Produce topologically arranged hair follicles via the delivery of skin stem cells using the "planar hair forming procedure". Using a modification of existing methods, we recently developed a procedure that allows multi-potential skin stem cells to form hairs with a correct planar configuration on mouse skin without a need for the cumbersome grafting chamber. The hairs run parallel to one another with a similar orientation. The contour of this hair reconstitution field can be flexible and irregular. Aim 2. Pre-arranging skin stem cells and their environment before delivery. Given one million cells capable of forming hairs, we may end up with 10 big hairs (useful) or 1000 small hairs (useless). Based on our experience of reaction - diffusion in feather reconstitution (Jiang et al., 1999), we will learn how to modulate this process by manipulating the micro- and macro- environments of hair stem cells. Aim 3. Sources of multi-potential skin stem cells and attempts to use reprogramming to make multi- potential skin stem cells We will try different cell combinations using epidermal and dermal cells that do not form hair follicles easily. We will use different factors to improve hair forming efficiency. We will develop lentiviral vectors for use in this assay. We hope to demonstrate that this assay can be used for high throughput assays to test the efficiency of factors involved in stem cell reprogramming. The success of this project will be judged by the following criteria: 1. Quantitative and qualitative control of hair growth from a wound. The architecture of the hair follicle will be analyzed and they should fulfill the criteria of re-establishing a sustainable episodic regenerative unit with proper tissue organization and cellular differentiation (Chuong et al., 2007). 2. Optimize the conditions to achieve a high and consistent yield of hairs. 3. Utilization of this protocol as a high throughput assay to screen conditions that enhance hair formation. The successful generation of reconstituted skin which can grow hair could be applied to future therapeutic treatments for patients suffering from burns and / or trauma over a significant portion of their bodies.